The Yale Maternal, Newborn and Child Health Promotion (MNCHP) Training Program

PROJECT SUMMARY/ABSTRACT
Maternal mortality has been steadily increasing, especially among underrepresented groups including Black
women, making it a top priority for the US government. Earmarked NIH funding has created valuable
opportunities for maternal, newborn, and child health (MNCH) researchers to tackle critical questions and
implement interventions to strengthen MCNH outcomes. Yet, implementing and scaling up evidence-based
maternal, newborn, and child health (MNCH) programs with fidelity and sustainability requires intensive
multidisciplinary training in implementation science, along with qualitative, quantitative, and mixed research
methods. A critical gap impeding further growth is the lack of rigorous training opportunities for young
investigators. Hence, the primary goal of this proposed program is to launch the first T32 program dedicated to
training pre-doctoral students and post-doctoral research fellows on the co-design, implementation, evaluation
and scale up of effective MNCH interventions from pregnancy through adolescence, with special focus on the
first 2000 days of life. This program will be guided by the principles of fidelity to community needs and wants,
equity, and dignity (FED). We seek applications from PhDs and predoctoral candidates from a wide range of
clinical and scientific disciplines and diverse personal backgrounds. The proposed program will take full
advantage of the outstanding resources of the Yale School of Public Health. The program's aims are to: [1]
Develop emerging scholars' cohorts with strong leadership and research skills necessary for advancing the
field of MNCH; [2] Develop MNCH focused implementation scientists that have the knowledge and skills to
become independent investigators and that adhere to the FED principles in their work; [3] Enhance the
diversity of MNCH implementation science researchers. Three distinguishing characteristics of this program
are: (1) emerging dissemination and implementation scientists will be cross trained in core areas critical to
MNCH implementation science including mixed-methods, maternal and child health epidemiology, nutrition,
and policy, as well as community engaged research; (2) the FED principles will be integrated into all training
aspects; (3) Mentors and resources represent an extraordinary breadth of disciplines from a wide array of
schools at Yale, including Medicine, Public Health, and Nursing, with expertise in MNCH epidemiology,
program, and policy; implementation science; mixed-methods; and health equity. Didactic components
leverage MNCH promotion coursework in a PhD academic pathway developed by PI Pérez-Escamilla and
mentor Spiegelman. A research internship will offer close mentorship from senior Yale Faculty experts in
MNCH promotion. Innovative skills development workshops will be offered. Trainee's progress will be
rigorously monitored and evaluated by the Program Director and mentors, with strong support from the
experienced Advisory Committee.

Public health relevance
PROJECT NARRATIVE Key informant interviews with maternal, newborn, and child health (MNCH) scientific leaders at global foundations and international health organizations identified training gaps in MNCH, especially in qualitative and quantitative implementation science training, and highlighted a deep need for a competitive, prepared MNCH workforce with strong knowledge and skills on mixed-methods implementation science methodologies. Yet, despite huge financial investments being made in addressing the unacceptably high maternal mortality and morbidity in the US, there are currently no training programs that teach the future workforce MNCH in the context of implementation science. This innovative program will fill this gap by cross training dissemination and implementation scientists in core areas critical to MNCH implementation science while integrating the social justice principles into all training aspects.